Characterizing Cancer Associated Fibroblast Evolution, Programming, and Fibroblast-Epithelial Cell Crosstalk in Pancreatic Ductal Adenocarcinoma

Characterizing Cancer Associated Fibroblast Evolution, Programming, and Fibroblast-Epithelial Cell
Crosstalk in Pancreatic Ductal Adenocarcinoma
Pancreatic adenocarcinoma (PDAC) remains one of the deadliest cancer diagnoses in the United
States with an abysmal overall 5-year survival rate of less than 15%. Unlike many other solid tumors
such as breast or colorectal cancers, treatment of pancreatic cancer is not dictated by molecular
subtypes of disease. A major barrier to developing precision-based treatments for pancreatic cancer
has been the pancreatic tumor microenvironment (TME). Cancer associated fibroblasts (CAFs)
comprise >80% of the TME and can either be tumor-promoting or tumor-suppressive in a highly context-
dependent manner. There is a critical unmet need to characterize CAF development and polarization
in PDAC to help develop effective treatments. In this proposal, we will test the central hypothesis
that CAFs co-evolve with epithelial cells during tumor progression, and that the molecular
subtype of PDAC can dictate stromal CAF composition. This hypothesis will be investigated
through the following specific aims: (1) Characterize the evolution of fibroblasts from normal pancreatic
tissue to adenocarcinoma. (2) Dissect the effects of fibroblast polarization by PDAC and assess subtype
specific programming. Together, this work will generate a temporal map of CAF evolution and can help
clarify subtype-specific TME features that can pave the way for new therapies.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is a deadly human malignancy with an overall 5-year survival rate of just 12.8%. Pancreatic tumors are characterized by a dense desmoplastic stroma with a prevalence of Cancer Associated Fibroblasts (CAFs). Here, we will investigate and map fibroblasts from normal pancreatic tissue to pancreatic ductal adenocarcinoma and elucidate whether pancreatic tumors directly program these cells; in doing so, we hope to contribute to critical gaps in our understanding of this disease.